ACTG--FLUCONAZOLE TREATMENT OF HISTOPLASMOSIS IN AIDS PATIENTS

This is a pilot study to determine the feasibility of using fluconazole for induction treatment and suppression of relapse of histoplasmosis in patients with AIDS.